Core B - Biological Analysis

SUMMARY – Core B: Biological Analysis Core (BAC)
The contribution of tissue-resident immune cells to the production of inflammatory senescence associated
secretory phenotype factors and the impact on the tissue environment is unknown, precluding the understanding
of immune senescence in aging and disease in tissue and organ specific context. In this project, a diverse group
of experts in aging biology, immunobiology, bioengineering, cell biology, and computational biology propose a
Yale murine Tissue Mapping Center for immune cell senescence (Yale-mTMC) through investigation of well-
defined lineage-marked mouse models by unbiased single-cell resolution OMICS approaches aims to discover
the cellular lineage of SASP producing cells and novel biomarkers that define stromal and immune-cell
senescence in vivo. The Biological Analysis Core (BAC) of Yale-mTMC will create the cellular senescence-
associated tissue atlases of thymus, bone marrow, spleen, PBMCs and mesenteric adipose tissue. In order to
detect and characterize rare senescent cells in vivo, construct the biomolecular and cellular map of senescent
cells in these tissues implicated in immune senescence, and dissect their impact on the tissue environment, the
BAC will deploy and combine three categories of bioanalytical pipelines including (i) 2D and 3D Multiplexed
Imaging (MI), (ii) Single Cell Analysis (SCA) of transcriptome and proteins, and (iii) Spatial Multi-Omics
Sequencing (SMOS), in order to achieve the sensitivity to detect rare senescent cells, the depth to characterize
the heterogeneity of senescent cells at the genome scale, and the breathe to map a wide range of cells in situ
to construct the maps of senescent cells and the associated tissue microenvironments. Specifically, the BAC will
pursue the following aims: (1) to provide biospecimens for analyses from lineage-marked mice with multiple
biological controls and authentication of senescence-models through co-operation with murine Tissue Mapping
Centers. (2) Implement an array of characterization pipelines for single-cell and spatial omics mapping of immune
cell senescence and the tissue environment, and (3) to scale and standard these pipelines by increasing the
assay speed and throughput in multiplex imaging and spatial multi-omics sequencing and by developing a fully
integrated and standardized workflow. Yale-mTMC's BAC brings several novel animal models and unique tissue
specimens that will be shared within SenNet as well as novel spatial multi-omics techniques that will enhance
the analytical capability of the consortium. It will generate a multi-omics molecular and cell atlas of senescent
immune cells in multiple lymphoid and non-lymphoid organs and collaborate with human SenNet teams to map
and identify common senescent signatures across tissue and species.